The Cellular and Neural Circuit Basis of Flexible Escape Behavior

PROJECT SUMMARY
In response to painful cues, protective withdrawal behaviors are triggered to reduce potential bodily insult. These
withdrawal behaviors are vital for survival and highly flexible depending on the ever-changing sensory context.
In pathological states, pain can be induced from otherwise innocuous stimuli like a gentle touch in cases of
allodynia, or one can become hypersensitive to pain in cases of hyperalgesia. How painful stimuli are detected
by primary nociceptors in the skin is well understood, as well as some of the nociceptive processing circuits that
relay this information to the brain. However, the neural mechanisms underlying the flexibility of escape and
withdrawal behaviors are much less understood, especially how these behaviors are altered in pathological
conditions. I propose to study the neural mechanisms that underlie multimodal integration of nociception and
mechanosensation that may allow for flexible escape behavior using Drosophila larvae, as this is the ideal model
organism to investigate this question. Larvae perform stereotyped escape behaviors in response to various
noxious stimuli. An abundance of genetic tools allows us to perform cell-specific and circuit manipulations, and
a synaptic wiring diagram of the larval central nervous system enables anatomical and circuit dissection at
nanometer resolution. We have found that mechanosensory neuron activation sensitizes escape behavior in
larvae and the relative balance of mechanosensory and nociceptive input may bias larvae to exhibit different
escape and mechanosensory behaviors. Here, I aim to 1) test the effect that different properties of
mechanosensory input have on generating flexible escape behavior through optogenetics and behavioral
analysis, and 2) determine the cellular and circuit mechanisms by which mechanosensory and nociceptive input
may be integrated via functional imaging and computational neuron modeling. This proposal will reveal general
principles of how mechanosensory and nociceptive input interact at the cellular and circuit levels to promote
flexible escape behaviors and provide insights for studying pain states and modulation in analogous vertebrate
systems.

Public health relevance
PROJECT NARRATIVE Flexible and protective withdrawal behaviors are essential for avoiding painful stimuli, but in pathological conditions people can become hypersensitive to pain or feel pain in response to otherwise innocuous sensory input. This proposal asks how properties of mechanosensory stimuli impact escape behavior and aims to understand how these signals may be integrated at the circuit level. This proposal will reveal potential mechanisms underlying behavioral flexibility in the context of escape and provide conserved insights for studying pain modulation at the cellular and circuit levels in analogous vertebrate systems.